Medical Scientist Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This application will support and renew the Medical Scientist Training Program (MSTP) at Stanford University School of Medicine. In over 50 years of continuous NIH funding, over 350 trainees have graduated from this program, many of whom have become leaders in their fields of academic medicine and biomedical research. Our program provides a superb environment and unique advantages for fulfilling our mission “to train a talented cohort of pioneering physician scientist (PS) leaders dedicated to a lifetime of biomedical discovery that improves human health through innovation.” Dual degree pre-doctoral training in the Stanford MSTP has durably produced successful outcomes in our trainees, based on several metrics used to compare MD/PhD programs nationally, including low attrition and time to degree conferral, publication record, and high retention of graduates in biomedical research careers. This proposal describes important elements of the Stanford MSTP. Program enhancements include a significantly increased level of institutional support, reflected in increased staffing and faculty effort to direct the MSTP; increased financial support for student training by the School of Medicine; integrated training in rigorous, reproducible, responsible and safe research conduct throughout the curriculum; improved mentoring and monitoring mechanisms for students throughout their training; enhanced career development training and physician scientist community building; new physician scientist training tracks for MD-only students, and enhanced integration of MD-only trainees in MSTP activities. Together, the increased institutional support, increased effort by School of Medicine faculty and leadership, dedicated program enhancements, and integration of clinical and graduate training have changed, expanded and improved the Stanford MSTP. Support through this proposal, heavily leveraged with School of Medicine and University resources, will support continuing innovation in training physician scientists at Stanford.

Public health relevance
Project Narrative Continued improvement in human health depends on the translation of fundamental knowledge to clinical settings, and the integration of approaches from several different disciplines. The Stanford MSTP embraces and promotes these goals, training physician scientists to be academic leaders for future advances in biomedical research.